UTA Summer Undergraduate Research Program to Promote Diversity in Health Related Research

Project Abstract/Summary
The overall goal of this R25 application is to provide unique research and education opportunities to current
underrepresented minority undergraduate students at the University of Texas at Arlington (UTA). Specifically,
we will expose these students to the disciplines of biomedical, behavioral, and clinical research with the ultimate
goal of enriching diversity in individuals who will represent the future in biomedical research in topics areas
related to the mission of the National Heart Lung and Blood Institute. UTA is a minority majority institution that
ranks among the top 5 in the nation for student ethnic diversity. As of fall 2020 UTA had a total of ~48,000 full
time on-campus students, the majority of which are undergraduate students (~35,000). The undergraduate
student body is comprised of 31% Hispanic, 15% African American, 13% Asian, and 5% International. In 2021
the U.S News and World Report ranked UTA fifth in the nation among institutions of higher education for ethnic
diversity. Furthermore, UTA is ranked #1 in the nation for “Best for Vets: Colleges” by the “Military Times”, thus
is ideally suited to accomplish the objective of increasing diversity in health-related research. We will enroll two
separate cohorts of underrepresented minority students: First, our selection committee will identify 10
outstanding sophomore, junior, and senior level undergraduate students from UTA (each year) to participate in
a “laboratory-based” summer research education experience. Second, our selection committee will identify up
to 40 underrepresented minority sophomore, junior, and senior level undergraduate students to participate in a
“classroom only” summer research education experience. Each cohort will participate in a 10-week summer
research / educational program, beginning the first week of June each year. Students in the “laboratory-based”
cohort will be assigned a primary faculty mentor who will supervise them in conducting fulltime research related
activities Monday through Thursday. On Friday’s, both cohorts come together for a joint “classroom-based”
research education experience, covering a wide range of topics related to biomedical research ranging from
Professional Development to the Responsible Conduct of Research. Students will also engage with URM faculty
and graduate students every Friday through a series of research seminars. The primary outcomes / metrics of
success will include: 1) Returning to the program for more than one summer experience (particularly for the
classroom-based cohort who will be strongly encouraged to reapply the following year for the laboratory-based
experience). 2) Successful completion of an undergraduate degree in a STEM field. 3) Applying for competitive
fellowships for graduate school or other advanced degrees. 4) Enrollment in an advanced degree program in a
STEM field. And 5) Subsequent participation in research or employment in a STEM field.

Public health relevance
Project Narrative The National Institutes of Health (NIH) has made it a priority to address a disparity in the participation of underrepresented minority populations in the biomedical, behavioral and clinical research workforce. The University of Texas at Arlington is a large research institution that has a minority majority undergraduate population (~35,000 undergraduate students) and thus is an ideal institution to address the need to promote diversity. This program will expose 50 different underrepresented minority undergraduate students each year for 5 consecutive years (250 students total), to a rigorous 10-week summer research education experience with the goal of increasing underrepresented minorities in the future biomedical research workforce.